(PQ1) HIV-infected T-cell exosomes in lung cancer progression

Project Summary/Abstract
Lung cancer (LCa) is the second most common malignancy in the US with about 222,500 new cases and
155,900 deaths each year. HIV-infected individuals and AIDS patients have increased relative risk of LCa by
250% after controlling for other potential risk factors. LCa in HIV+ people under antiretroviral therapy (ART) is
diagnosed at younger ages than those in the general population. This trend in the ART era is implicitly
attributed to prolonged life span and aging of the population. The success of new approaches to control lung
tumorigenesis in the population is contingent to identify HIV-specific mechanisms that facilitate the tumor
progression and metastasis. HIV-infected T cells release a variety of immunologically active exosomes, small
vesicles of endocytic origin, to influence intercellular communication and material transfer at both local and
distant sites, thus potentially contribute to enhanced risk for tumorigenesis. Our preliminary studies have found
that exosomes secreted by HIV-infected T cells and purified from the blood of lung cancer patients of people
living with HIV (PLWH) significantly stimulated lung cancer cell proliferation. HIV-associated exosomes induced
MAP kinase ERK1/2 activation via interaction with epidermal growth factor receptor (EGFR) and the toll like
receptor 3 (TLR3). Mechanistically, the HIV trans-activation response (TAR) element RNA, which exists in
excess of other HIV RNAs in exosome from HIV-infected T cells, is responsible for enhanced cancer cell
proliferation and proto-oncogene expression. We have established a bone marrow transplant (BMT) mouse
model in which lethally-irradiated FVB mice were grafted with syngeneic bone marrow cells of Tg26 HIV-
transgenic mice. Growth and metastasis of allografts LCa cells were significantly enhanced in grafted mice
containing HIV+ bone marrow cells compared with that in non-grafted control mice. However, reconstitution of
circulating immune cells and bone marrow remained the same between two groups of mice, suggesting that
TAR RNA-bearing exosomes from reconstituted HIV+ immune cells may promote LCa progression in the BMT
model. Taken together, these data lead us to hypothesize that TAR RNA-bearing exosomes from HIV-infected
immune cells promote lung cancer growth and progression and that controlling release of the exosomes or
directly targeting the TAR RNA may serve as an adjuvant for prevention and treatment of lung cancer in HIV-
infected individuals. To test this hypothesis, we will first delineate the mechanism by which HIV-1-infected T-
cell exosomes stimulate LCa growth and progression in vivo using the BMT model. The potentials for
therapeutic intervention of LCa promotion by HIV will be examined through inhibition of exosome production
and neutralization of TAR RNA. Finally, we will comprehensively examine the HIV-positive exosomal
membrane proteins for interaction with EGFR and HIV-specific cargo components in the circulation using our
novel EV-omics approach. Completion of the proposed studies will shed light on the mechanisms underlying
HIV-mediated promotion of LCa and lay a foundation for therapeutic intervention of non-AIDS-defining cancers.

Public health relevance
Project Narrative Lung cancer is the second most common malignancy in the US with Human immunodeficiency virus (HIV)-infected individuals and AIDS patients at increased relative risk by 250% and younger diagnosis. HIV-infected cells secrete extracellular vesicles, such as exosomes, into the blood and other body fluids which we found to stimulate lung cancer growth in HIV-infected persons. This research will help us understand why and how HIV-associated exosomes promote cancer and find a new method to control lung cancer development and progression in the population of persons living with HIV.